Extracellular RNA carrier subclasses in processes relevant to Substance Use Disorders or HIV infection

Abstract/Project Summary
Emerging preclinical data and clinical evidence support the existence of a bidirectional communication between
the gut microbiome and the central nervous system. Recently, the gut microbiome has been shown to play a
critical role in the development and function of the central nervous system (CNS). While advanced age as well
as immune and metabolic alterations can lead to increased permeability of tissue barriers, evidence shows gut
microbes signal to the brain even in young, healthy humans and in animal models. Signaling through the vagal
nerve may play a role in these situations, but the exact mechanism of this communication remains to be
confirmed. Bacterial extracellular vesicles (BEVs) have recently been shown to carry information over long-
distances modulating interkingdom communication within the gut microbiota brain axis. Both gram negative and
more recently gram-positive bacteria have been shown to release extracellular vesicles. These vesicles have
been shown to contain a variety of biomolecules, such as proteins, lipids, nucleic acids, and small-molecule
metabolites and play a key role in the biology of bacteria. BEVs has been postulated to be the key underlying
mechanisms behind harmful or beneficial effects of many pathogenic, symbiont, and probiotic bacteria. Opioid
use disorders have been associated with dramatic alteration in the gut microbiome with the expansion of gram-
positive bacteria. Similarly, in humans and in animal models HIV infection is associated with microbial changes
resulting in elevated systemic endotoxin levels-a signature marker for HIV co-morbidity. Opioid abuse
exacerbates these effects both in PLWH and in animal models of HIV and substance use. The role of bacterial
extracellular vesicles in modulating the gut brain axis under these conditions has not been investigated. This
high risk, high reward R21 proposal is a pilot grant to establish proof of concept. Based on preliminary data and
published studies, we hypothesize that microbial dysbiosis associated with opioid use and in the context of HIV,
results in the expansion of distinct pathogenic bacterial communities leading to the secretion of BEVs which
acts as mediators that communicates with both immune cells and microglial cells to disrupt the gut-brain-axis.
Two specific aims are proposed to test this novel hypothesis. Specific Aim 1: Determine if bacterial EV’s
derived from fecal samples from Control, Morphine dependent, HIV/ART and Morphine
dependent/HIV/ART treated mice a) disrupt gut epithelial and brain endothelial barriers and b) cross gut
epithelial and blood brain barriers using in vitro gut epithelial and blood brain barrier models. We will
further investigate if BEVs modulate macrophage and microglial gene expression in co-cultures. Specific
Aim 2: Determine if Extracellular vesicles isolated from fecal samples from Control, Morphine dependent,
HIV/ART and Morphine dependent/HIV/ART treated mice a) disrupt epithelial barrier b) increase gut
epithelial permeability and c) cross gut epithelial barrier and Blood brain barrier in vivo. The clinical
relevance of these studies is that BEVs can be exploited for therapeutic purposes to deliver nano
pharmaceuticals systemically and to the CNS.

Public health relevance
Project Narrative There is a strong correlation between chronic drug use and increase susceptibility to HIV infection. Chronic drug users accounts for approximately a third of all cases of AIDS in the USA and the progression to HAND is markedly accelerated in opiate drug abusers; currently most HIV patients are on ART however, the long term consequence on neurocognition has not been delineated. This proposal postulates that alteration in the GUT microbiome results in the secretion of Bacterial extracellular vesicles that are able to cross barriers and travel long distances to modulates microglial cells thus contributing to neurocognitive deficits that are persistence in people living with HIV that are substance users.